IND-enabling studies and phase I clinical trials to advance CD74-target, DRhQ, as a treatment for stimulant use disorder

PROJECT ABSTRACT
Methamphetamine (MA) is a highly addictive central nervous system (CNS) psychostimulant. MA causes long-
term damage to regions of the brain that regulate cognitive and psychiatric functions and promote drug-seeking
behavior, consequently, recovery from MA addiction is extremely difficult. The current standard of care for
stimulant use disorder (SUD) is behavioral therapy but, unfortunately, the majority of patients relapse to MA use
within one year after treatment. There are currently no FDA-approved pharmacotherapeutics for MA use disorder
(MUD). Emerging evidence demonstrates how immune factors can influence addictive behaviors and contribute
to SUDs. We have a collection of MHC class II constructs that bind to and downregulate the expression of
CD74—the primary receptor for macrophage migration inhibitory factor (MIF), a key inflammatory indicator in
SUD, as well as other diseases. These constructs have therapeutic impact on drug-seeking and drug-taking
behavior, and can also impact cognitive function, and inflammation-associated with exposure to MA, suggesting
a more effective therapeutic profile than previously developed targets. The primary objective of this UG3/UH3
proposal is to advance our current generation molecule, DRhQ, which has been optimized for CD74 binding,
through phase 1 safety trials in both healthy volunteers and in individuals with MUD who also test positive for
MA. The UG3 portion of the grant includes using rat animal models to determine the dose and dosing schedule
of DRhQ, in its final monomeric formulation, that reduces drug-taking behavior in a progressive-ratio schedule
of self-administration and whether DRhQ reverses CNS neuropathology in an innovative compulsive MA use
model. Large-scale manufacturing of DRhQ will be completed to support toxicology studies and the phase 1
clinical trials. Following the toxicology studies in both rats and dogs, an investigational new drug (IND) application
will be submitted to the FDA for the proposed phase 1 clinical trials. An open IND will be the milestone for
transitioning from the UG3 to the UH3. In the UH3, a single ascending dose (SAD) study and a multiple
ascending dose (MAD) study will be completed in healthy volunteers. A second phase 1 safety study will be
conducted in participants diagnosed with MUD who also test positive for MA to address the potential interaction
between MA and DRhQ in patients. At the end of this proposed round of funding, we will have completed first-
in-human (FIH) studies that will determine the safety of DRhQ. If found safe, the studies supported by this grant
would enable larger phase 2 efficacy studies in individuals seeking treatment for MUD.

Public health relevance
PROJECT NARRATIVE There are currently no FDA-approved treatments for methamphetamine use disorder. We have an innovative new therapeutic, DRhQ, that improves cognitive function, decreases drug-seeking behavior, and reduces inflammation following methamphetamine use in animal models. This proposal aims to move DRhQ through phase 1 safety studies which are critical steps in advancing the drug into the clinic.